VISUAL COMPETENCE IN EARLY INFANCY

This is a competing continuation application for a Research Scientist Award. My broad objective for this project is to continue my research and conceptualization efforts in the area of the development of future-oriented processes. The core research effort will be in human infancy where we study the baby's ability to form visual expectations through the first year of life. This project will constitute the majority of my research effort. Typically, we index babies' expectations by their anticipatory eye movements and reaction times to visual events. Issues in five domains will bc addressed: 1) what information babies use to form expectations, 2) development change and individual differences in babies' tendencies to form expectations, 3) whether babies code expectations in terms of rules as opposed to expectations being completely embedded in action, 4) the extent to which babies can form expectations for increasingly complex rules with age, and 5) whether babies' ability to form expectations for discrete events that they do not control relates to their expectation for continuous events and/or events that they can control. In addition to this core effort, I have several branch objectives for continuation of collaborations in which I play a less major role. The first of these involves research on the genetics of intelligence through application of the infant visual-expectation paradigm to twin-infant studies and through follow-up of infants into early childhood where we measure both visual and manual anticipation and reaction time. A second objective concerns research on perception-action components of skilled behavior. Still a third branch objective involves research aimed at assessing what future-oriented domains develop between 9-36 months of age and 3-7 years of age, using interview and questionnaire techniques at first, with an aim to develop new experimental paradigms. A final aim is to promote the area of the development of future-oriented processes as an important field of study through continuing leadership of a national MacArthur-funded research interest group.